SToP Cancer SPORE: Career Enhancement Program

CAREER ENHANCEMENT PROGRAM: ABSTRACT
The primary objective of the Career Enhancement Program (CEP) of the UNC Pancreas SPORE is to augment the career development of faculty members from diverse fields who will focus on pancreatic cancer research. This will be accomplished by 1) providing financial support to develop and enhance the research effort of these faculty and 2) to provide both clinical and laboratory mentoring for investigators who are new to the field. We intend to foster the research careers of translational investigators working in pancreatic cancer. The CEP will select investigators for support from the entire spectrum of translational research in pancreatic cancer; including those working in public health areas of prevention and early detection, diagnosis and other pertinent areas of population science; basic science investigators working to translate their findings to patient care in the clinic and translational/clinical investigators working to improve the outcome for patients with pancreatic cancer. We will support highly qualified investigators who are new to the field of pancreatic cancer with a focus on early career or mid-career investigators transitioning to work in this area.

The CEP is led by Jonathan Serody MD Associate Director for Translational Science at the Lineberger Comprehensive Cancer Center and Elizabeth Thomas Professor of Medicine, Microbiology and Immunology. The co-leaders are supported by the CEP Advisory Committee (CEPAC) and our patient advocates. Applicants will be selected from the highly qualified pool of investigators.

Financial support will be for an initial period of one year, that will be renewable if there has been appropriate translational progress. We will collaborate with our partner institutions to strengthen multi-institutional collaborations as the CEP matures.

Public health relevance
CAREER ENHANCEMENT PROGRAM: PROJECT NARRATIVE The Career Enhancement Program of the UNC Pancreatic cancer SPORE prepares the next generation of translational pancreatic cancer researchers.